Research and Technological Innovations in Automation, Robotics, and Intelligent Mining Systems for Transformative Improvements in Workplace Safety, Health, and Efficiencies

RESEARCH PLAN – ABSTRACT
The U.S. mining industry has advanced technological innovations to improve safety, and health.
These technologies have reduced accidents and fatalities over the years. However, the industry has
one of the most dangerous environments for workers. The 2021 fatality rate of 16.15 was four
times the average rate for all US industries. Autonomous, robotic, and intelligent (ARI) systems
are the next frontiers for achieving zero fatality. This proposal will therefore advance research
initiatives, technological innovations, and interventions in ARI systems to eliminate mine fatalities
within the next two decades. The program will be carried out under the MERIT (Mine Escape,
Research, Innovations and Technology) Center at Missouri University of Science and Technology
(S&T) in collaborations with New Mexico Institute of Mining and Technology (NMT), the mining
industry and NIOSH.
The proposal will (1) develop intelligent data analytics using artificial intelligence (AI) and
machine learning (ML) algorithms for analysis, predictions, and process management to assure
ARI systems; (2) develop cyber and systems network security to secure, protect, and prevent
adversarial attacks against ARI systems; (3) develop an integrated human-centered design and
change management system within human-centered operations for the new intelligent paradigm to
ensure smooth operations; (4) develop an intelligent communication system for bulk data transfer
with embedded systems for data warehousing, processing, and usage to provide 360O vision and
prevent collisions; (5) develop intelligent robot assistance in mining for safe operations in high-
temperature areas, areas with toxic and explosive gasses, or tight spaces for equipment
maintenance; and (6) create intelligent mine rescue and post-disaster surveillance for the emerging
ARI systems.
The PD and another Co-PI hold full-time academic positions in mining and explosives engineering
at S&T and NMT. S&T offers an ABET-accredited mining engineering program. It also offers
Master of Engineering (M.E.), Master of Science (M.S.), Doctor of Philosophy (Ph.D.) and Doctor
of Engineering (D.E.) in mining engineering. S&T also offers M.S. and Ph.D. degrees in
explosives engineering (https://mee.mst.edu/degrees/). One PI, from NMT, also holds a full-time
academic position in mineral engineering. NMT also offers an ABET-accredited undergraduate
and M.S. and Ph.D. degrees in mining engineering with research in explosives engineering
(https://www.nmt.edu/academics/index.php). S&T’s Experimental Mine and Explosives Research
Facilities, NMT’s Mining Research Facilities, and other research labs provide unparalleled
environments, and resources to undertake this initiative.
This initiative is a collaborative, multi-university, and multi-disciplinary effort that brings together
researchers from mining and explosives, electrical and computer, and mechanical and aerospace
engineering, engineering management and systems engineering, computer science and
psychological science. The research team will interact with CDC-NIOSH and fulfill all
requirements. This initiative will expand knowledge and capacity in mine automation, robotics,
and other intelligent systems, develop intelligent mine rescue and post-disaster surveillance, and
transfer technologies into industry through research-to-practice approach. We will disseminate
research results in journals and conference proceedings and establish an arms-length Industry
Research Advisory Board (IRAB) to provide counsel on research directions. The IRAB members
include Arch Resources, Komatsu America Corporation, Peabody Energy Corporation, Fred
Weber Inc., Matrix, MSHA, Strata, and Vale. To achieve these research goals, S&T and NMT
request $2 million per year funding, within the 4-year duration.

Public health relevance
PROJECT NARRATIVE The U.S. mining industry has advanced technological innovations to improve safety, health, and environmental impacts. These technologies have reduced accidents and fatalities over the years. For example, the number of fatalities decreased by 65% from 206 in 1984 to 71 in 2010. The fatality rate also decreased by 56% from 58.43 to 25.74 within the same period. However, the industry has one of the most dangerous environments for workers. The 2021 fatality rate of 16.15 was four times the average rate for all US industries. Autonomy, robotics, and intelligent (ARI) systems are the next frontiers for addressing the grand challenges of mining fatalities. ARI systems will greatly improve safety, health, and efficiencies. However, current applications have minimal safeguards to ensure the safety of ARI-human interactions. These minimal safeguards increase the probability of accidents and fatalities, conflicting equipment protocols, risks and hazards, and erroneous intelligent responses, resulting in human and economic losses.